Investigating the role of the conserved transcriptional regulator Apterous on muscle development

PROJECT SUMMARY
There is a critical need to develop treatments for muscle wasting, which increases morbidity and mortality of
patients suffering from muscular dystrophies, myopathies, cancer, kidney failure and pulmonary disease. Stem
cell therapies require the ability to generate muscles of particular sizes and shapes to replace damaged
muscles in, for example, the round eye or the elongated limb. A thorough understanding of how muscles with
specific properties develop will allow us to "program" muscle cells to adopt specific properties, a key step
towards developing these kinds of treatments. The long term goal of the proposed work is to use the fruit fly,
Drosophila melanogaster, to determine the cellular mechanisms underlying the development of somatic
muscles with distinct sizes, shapes, orientations, innervations, attachments and gene expression patterns.
Within each muscle these properties are encoded by distinct sets of gene regulatory factors, including the
conserved genes Apterous (Ap), Midline (Mid), and Muscle-segment homebox (Msh). We are focused on a
subset of embryonic abdominal muscles that express Ap, Mid and Msh. We have found that expression of Ap
outside its normal pattern dramatically disrupts the musculature, leading to changes in muscle positioning and
loss of muscle attachments. The failure of the muscle-tendon connection prevents these mutant embryos from
generating the force needed to hatch from its eggshell and leads to death. Our hypothesis is that Ap directly
regulates genes involved in muscle orientation and the selection of direct versus indirect muscle attachment by
functioning in a network of gene regulators including Mid and Msh. We will test this hypothesis with three Aims:
1) examining the location and level of muscle guidance and attachment factors in Ap mutant backgrounds; 2)
identifying the genes regulated by Ap; and 3) determining the interactions between Ap, Msh and Mid during
muscle development. The proposed work combines gene expression analyses with cell biology, microscopy
and genetics to learn how muscle connections are made and determine how many genes are targets of Ap
regulation. Taken together, the experiments described in this proposal will determine how muscle properties
like shape, orientation and attachment type are specified, which will inform our understanding of the vertebrate
orthologs of muscle development in humans and lead to the development of therapies.

Public health relevance
PROJECT NARRATIVE My research focuses on muscle cell development, an area with significant health implications, because muscle wasting affects not only children and adults suffering from muscle disease, but is a side effect of aging, cancers, cardiac and pulmonary diseases. This proposal uses the fruit fly model organism to investigate how changes in gene expression lead to the generation of muscles with diverse properties like size and shape. These studies will identify genes and mechanisms which may provide targets for therapeutics, and which will inform the development of stem cell transfer therapies to treat muscle wasting due to disease or aging.